COMBINED CLINICAL, VIRAL, AND IMMUNOLOGICAL STUDIES OF NEUROMUSCULAR DISEASES

Clinical and laboratory studies are conducted to determine etiology (infection, immunity and-or genetics) of chronic diseases of the neuromuscular system and design effective therapies. Current studies involve patients with polymyositis-dermatomyositis, post-polio syndrome, amyotrophic lateral sclerosis (ALS), demyelinating polyneuropathies, neuromuscular diseases associated with HIV infection, hypokalemic periodic paralysis and Duchenne muscular dystrophy. The pathogenesis of post-polio syndrome is explored with a series of electrophysiological, virological, immunological and histological studies. The findings are compared with those seen in patients with acute paralytic poliomyelitis and other motor neuron diseases. Persistent or mutant poliovirus is sought in these patients' tissues using tissue cultures, PCR, and in situ hybridization. Because abnormal immunoregulation was found in some patients, a double-blind placebo-controlled trial using prednisone was conducted. The mechanism of post-polio fatigue, a common and disabling symptom in many patients, is under study using magnetic resonance spectroscopy. Sequence of the beta amyloid precursor protein gene is performed in patients with familial and sporadic inclusion body myositis. The spectrum of neuromuscular disorders associated with HIV infection has been studied and the role of the virus in the cause of neuropathy or myopathy is investigated with a variety of immunocytochemical studies, in situ hybridization and PCR. The antiretroviral drug AZT was found to cause an unique myopathy characterized by abnormal mitochondria as deter-mined by various morphological, molecular, biochemical and immunocytochemical studies. A longitudinal study of HIV-positive patients that develop myopathic symptoms while on AZT is conducted with serial muscle biopsies to assess factors associated with the development of myopathy. Patients with AZT-myopathy were found to have low muscle carnitine level. This has prompted carrying out an ongoing randomized controlled clinical trial using oral L-carnitine. Randomized-controlled clinical trials are conducted with high-dose intravenous immunoglobulin in patients with polymyositis-dermatomyositis, chronic inflammatory and paraproteinemic demyelinating polyneuropathies, amyotrophic lateral sclerosis and Duchenne muscular dystrophy. A controlled study using dichlorophenamide, a carbonic anhydrase inhibitor, is also conducted in patients with hypokalemic periodic paralysis.